Phenotypic Analysis of SLC17A5 Neuromodulation in Salla Disease

Project Summary/Abstract
The human SLC17A5 gene encodes a constituent of the lysosomal cell membrane of neurons, a proton-
coupled transporter protein termed Sialin. This solute carrier protein has several defined activities, including
the transport of the negatively charged sugars, glucuronic and free sialic acid, out of lysosomes for use in
glycoprotein and glycolipid formation. Diseases associated with mutations in SLC17A5 are autosomal
recessive neurodegenerative disorders that, depending on the mutation, manifest either as a severe infantile
sialic acid storage disorder that leads to lethality in early childhood, or as Salla disease, a milder, slowly
progressive adult form characterized by intellectual disability, ataxia, hypomyelination, hypotonia, epilepsy, and
neurodegeneration. These are very rare and understudied conditions; it is estimated that there are less than
1,000 individuals with Salla disease in the United States. This R03 proposal is associated with RFA-TR-22-
030 for Pilot Projects to Investigate Understudied Proteins Associated with Rare Diseases. Here, we will
model two prominent symptoms associated with Salla disease: epilepsy and neurodegeneration, using the
nematode model organism, Caenorhabditis elegans, to circumvent the premature lethality resulting from
SLC17A5 deletion in mice. The C. elegans slc-17.2 gene product shares over 55% similarity with human
SLC17A5/Sialin and is widely expressed within neurons. In Aim 1, we will examine viable slc-17.2 CRISPR-
generated null mutants for epileptic-like convulsions. C. elegans is well-studied for factors that influence
neuronal excitability. Using two complimentary experimental paradigms, both involving a chemical-genetic
approach to incite hyperexcitability in either cholinergic or GABAergic neurons, slc-17.2 mutants will be
evaluated for evidence of convulsive behaviors with and without slc-17.2 expression. To reveal functional
modifiers of a convulsive phenotype, we will perform a systematic genetic analysis of 10 conserved candidate
targets corresponding to gene products listed as protein-protein interactors with human Sialin in the NIH
Pharos database. Existing mutants for each of these candidates will be crossed to slc-17.2 knockout animals
to screen for modifiers of convulsion phenotypes. In Aim 2, we will employ a complementary strategy to model
the progressive nature of Salla disease by examining C. elegans slc-17.2 mutants for an impact on dopamine
neuron degeneration as animals age. As in Aim 1, a systematic genetic analysis of the same 10 candidate
interactors of SLC17A5/Sialin will be conducted to uncover modifiers of any SLC17A5 effects on C. elegans
dopamine neurons. Candidate effectors will be parsed rigorous quantification of neurodegeneration, at the
single neuron level, in isogenic populations, using different mutant backgrounds. This 1-year study will
establish a platform for preclinical screening of factors that can correct or compensate for the lysosomal
deficits caused by SLC17A5 mutation. Our approach exemplifies how intact invertebrate models can facilitate
the ascription of functions to understudied proteins and accelerate mechanistic understanding of rare diseases.

Public health relevance
Project Narrative Salla disease is a rare lysosomal storage disorder linked to heritable autosomal recessive mutations in the human SLC17A5 gene, encoding a transporter protein on the membrane of lysosomes that is needed for export of recycled sugar molecules used in glycoprotein and glycolipid formation. Studies have been limited in scope due to the premature lethality associated with mutations in SLC17A5 that result in an acute accumulation of sugars within the lysosome and cause a severe infantile sialic acid storage disorder (ISSD), whereas Salla disease is characterized by weaker mutations that result in a more slowly progressive adult form of neurodegenerative disease. Here we will develop a new animal model of Salla disease that circumvents the lethality of ISSD and other models through use of genetic and pharmacological combinations designed to uncover neuromodulators of SLC17A5 and enable the examination of two primary symptoms – convulsions and progressive neurodegeneration, to accelerate the path of therapeutic discovery for adults with this rare disorder.